Catalyzing visual-haptic acuity for tissue handling mastery in robotic minimally invasive surgery

ABSTRACT
A signiﬁcant portion of the technical errors made by surgical trainees involve the improper use of force on
patient tissue. For robotic minimally invasive surgery (RMIS), the improper force problem is exacerbated by the
lack of haptic feedback of tool-tissue forces. Expert RMIS surgeons have learned over time to visually estimate
these forces in a process known as visual-haptic acuity development. Unfortunately, no training tools currently
exist for explicitly catalyzing visual-haptic acuity development in RMIS trainees. The overall objective of this
early-stage trailblazer application is to develop and validate an innovative training tool that catalyzes visual-haptic
acuity with titrated supplemental haptic feedback. The central hypothesis is that visual-haptic acuity is a critical
component of tissue handling skill in RMIS that can be augmented during simulation-based RMIS training using
titrated psychomotor-skill speciﬁc haptic feedback and assessed using robust measures of tool-tissue interac-
tions. The rationale for this project is that tools to support development of visual-haptic acuity provides surgical
educators and training institutions with the means to ensure every RMIS surgeon has mastered the tissue han-
dling skill necessary to safely operate on patients. The central hypothesis will be tested through the pursuit of two
speciﬁc aims: 1) Accelerate learning of RMIS visual-haptic acuity using titrated supplemental haptic feedback of
tool-tissue forces and tissue-contact accelerations, and 2) Assess and predict RMIS visual-haptic acuity during
simulated surgical training. In the ﬁrst aim, user studies will be conducted to discover and evaluate the optimal
haptic feedback titration approach for fostering visual-haptic acuity. In the second aim, structured human grading
and data-driven methods will be developed and validated to predict and assess visual-haptic acuity, and the efﬁ-
cacy of these approaches will be assessed through surgical task performance on cadaveric tissue. The proposed
research is innovative because it focuses explicitly on the development of new tools capable of augmenting and
assessing visual-haptic acuity, a critical component of tissue handling skill in RMIS. The proposed research is
significant because it will provide an objective, quantiﬁable, and repeatable means of accelerating tissue handling
mastery in RMIS, thereby improving the overall safety of RMIS procedures, regardless of RMIS platform. Suc-
cessful completion of these aims therefore enables the creation of validated curricular tools for training the critical
psychomotor skills required to reduce iatrogenic tissue injury in RMIS.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it focuses on the development of a tissue handling training tool for robotic minimally invasive surgery. This tool will play a critical role in ensuring patient safety by reducing the occurrence of iatrogenic tissue injury. Thus, the proposed research is relevant to NIBIB's mission because it integrates state-of-the-art engineering techniques with pioneering medical expertise to create tools that advance the treatment of disease.